Mechanisms of visual transduction and light-driven behaviors in Aedes aegypti

Abstract
The goal of this project is to break fundamentally new ground by investigating the molecular basis of vision in
the daytime mosquito vector, Aedes (Ae.) aegypti. This mosquito is a major disease vector, which transmits the
viruses that cause dengue, yellow fever, Zika and other diseases that affect many tens of millions of people
each year. Due to climate change and travel, this invasive species is spreading to new locations, including
multiple areas in the United States. Therefore, innovative strategies to control mosquito borne disease are
urgently needed. Female Ae. aegypti detect and integrate multiple sensory cues to locate human hosts. Once
they sense CO2 odor plumes emanating from human breath at distances of up to 10-15 meters, their visual
attention to potential hosts is greatly increased. They then rely on visual information along with other human-
derived cues, such as organic olfactory stimuli, to home in on people. Despite the important contribution of
vision in promoting the ability of Ae. aegypti to find humans, there has been no comprehensive approach to
apply molecular genetics to define the mechanisms underlying vision and odor-stimulated vision-guided host
attraction. The objective of the proposed research is to address this gap. Aim 1 is to define the roles of the
TRP and TRPL channels in Aedes vision. We have recently used CRISPR/Cas9 to generate mutations that
disrupt the trp and trpl genes. We propose to examine the roles of these channels for the light response in
photoreceptor cells. We also outline experiments to investigate potential roles for these channels in several
vision- and light-driven behaviors, including CO2-stimulated vision-guided target attraction. The goal of aim 2 is
to test the idea that the two phospholipase C genes expressed in the eyes of Ae. aegypti (NORPA and
PLC21C) have distinct roles in visual transduction and in multiple vision- and light-driven behaviors, including
circadian rhythms. We will also address the impact of mutations disrupting norpA and plc21C in combination
with mutations that disrupt cryptochrome, which encodes a light sensitive protein in the insect brain. Ae.
aegypti are most active and bite primarily after sunrise and before sunset. Therefore, understanding the
regulation of circadian rhythms in this organism is important, and the contributions of retinal proteins to this
behavior represents another major gap in our understanding of the biology of Ae. aegypti. Aim 3 focuses on
testing an iconoclastic role for the Gaq in the light response. In addition to its classical role as an effector
protein for rhodopsin, we will test the idea that Gaq directly regulates the TRP and TRPL channels. To
accomplish our goals, we propose to employ a multidisciplinary approach, including electrophysiology,
molecular genetics, biochemistry, cell biology and a wide diversity of behavioral assays. We propose that these
studies will provide the conceptual framework for devising innovative strategies to limit the ability of these
mosquitoes from efficiently locating hosts and spreading disease.

Public health relevance
Project narrative The mosquito disease vector, Aedes aegypti, is troubling because it spreads viruses that cause diseases such as dengue, yellow fever, and Zika, which infect >100,000,000 people/year. Once this daytime biting mosquito senses CO2 from our breadth, they then home in on people using visual and other cues. Despite the importance of vision in finding humans, our understanding of the visual mechanisms that mosquitoes use to find people are largely unknown. The goal of this application is to fill this gap. This project lays the conceptual foundation for devising innovative approaches to limit the ability of mosquitoes in detecting hosts for blood meals.